Efficient and Modular De Novo Synthesis of Hydroxycarvone Derivatives via Pd-Catalyzed Conjugate Addition: Application to theTotal Synthesis of Phorbasone A

Project Summary:
There is a lack of development of a robust, efficient, and modular synthesis of cis-γ-hydroxycarvone building
blocks. The importance of this motif is highlighted by its presence in a variety of biologically active alotane derived
natural products. The existence of this gap represents an important problem because until it is addressed, the
synthesis of these biologically, and structurally interesting natural products will be confined to the amenability of
carvone itself to subsequent functionalization. The studies described in this proposal seek to introduce new
concepts and reactivity in the realm of Pd-catalyzed conjugate addition chemistry to efficiently synthesize cis-γ-
hydroxycarvone building blocks. The rationale for the proposed research is that efficient access to cis-γ-
hydroxycarvone building blocks will allow alotane derived natural products to be more accessible.
Consequentially, increased access to these natural products will aid in biological evaluation, and understanding
of the mechanism by which they are effective. This will be realized by pursuing two specific aims: 1) Development
of a robust, scalable, and divergent route for the synthesis of cis-γ-hydroxycarvone derivatives, and 2) the total
synthesis of phorbasone A. Under the first aim, introduction of new methods and concepts in Pd-catalyzed
conjugate addition will be pursued. Development of a Pd-catalyzed enantioselective conjugate addition of
vinylboronic acids to quinone monoketals will allow for the efficient synthesis of cis-γ-hydroxycarvone building
blocks. Introduction of this method will also reach beyond the scope of the synthesis of cis-γ-hydroxycarvone
derivatives, as the products of the reaction contain a dense array of synthetic handles that can be precisely
functionalized at will. This approach is innovative, because the use of quninone monoketals as substrates for
conjugate addition has been very underdeveloped, despite the synthetically versatile nature of the products
formed. Under the second aim, an efficient de novo synthesis of cis-γ-hydroxycarvone derivatives will allow for
the synthesis of a never before synthesized natural product, phorbasone A. While the second aim is not
dependent on the success of the first aim, accomplishment of the first aim would allow for a more efficient
synthesis of the requisite cis-γ-hydroxycarvone derivative when compared to other known alternative routes. The
proposed research is significant, because introduction of more efficient methods to construct cis-γ-
hydroxycarvone building blocks will allow biologically active alotane natural products to be more accessible. This
will positively affect human health by aiding in further biological evaluation of alotane natural products.

Public health relevance
Project Narrative: The proposed research is relevant to public health because the introduction of new methods to efficiently access biologically active natural products will aid in their study and application to new pharmaceutical treatments. Introduction of new methods to efficiently access cis-γ-hydroxycarvone building blocks will grant access to alotane derived natural products, which elicit a wide variety of biological activities. The project is relevant to the NIH’s mission that pertains to developing fundamental understanding that will aid in accessing natural products that will help to treat disease.